Behavioral and Neural Correlates of Post-Stroke Fatigue

PROJECT SUMMARY
Up to 85% stroke survivors experience post-stroke fatigue (PSF) defined as intensified
perceived effort during activities. PSF is a significant barrier to full participation in rehabilitation
and negatively affects quality of life after stroke. Despite its well-known impacts, there are very
few targeted interventions for PSF largely due to unclear underlying mechanisms. A few brain
stimulation studies have suggested a relationship between primary motor cortex (M1) excitability
and PSF. Recent clinical trials using anodal transcranial direct current stimulation (tDCS) to
modulate brain excitability reported mixed clinical efficacy in reducing PSF with unclear
mechanisms of action. The proposed research will address the gaps in our knowledge by
determining the behavioral and neural correlates of PSF using an experimental design and
multimodal approach. Thirty-two individuals with significant fatigue due stroke will be randomly
assigned to receive five consecutive sessions of anodal or sham tDCS. Before and after
intervention, participants will complete clinical and behavioral assessments of PSF, brain
excitability assessment using transcranial magnetic stimulation, and brain connectivity
assessment using resting state functional MRI. In aim 1, we will determine if upregulating M1
excitability via tDCS will reduce PSF assessed by clinical and behavioral markers. Aim 2 will
utilize brain stimulation and brain imaging techniques to probe the neurophysiological effect of
tDCS on PSF. Aim 3 will explore the correlation between behavioral changes and
neurophysiological changes to provide further insights into the neural correlates of PSF. Our
long-term goal is to develop evidence based, theory-driven interventions to manage PSF. The
proposed study is innovative in that it investigates a relative novel intervention to mitigate PSF
and adopts a multimodal approach to examine the underlying mechanisms. The comprehensive
research will guide the development of treatment targeted the underlying mechanisms of PSF.
In addition to its scientific and clinical significances, the proposed research will achieve its
educational goals by fostering a group of student researchers and promoting rigorous research
cultures within our institute.

Public health relevance
PROJECT NARRATIVE Many individuals with stroke suffering post-stroke fatigue (PSF), a debilitating symptom negatively impact quality of life after stroke. In the proposed research, we will use novel brain stimulation and brain imaging techniques to determine the behavioral and neural effects of brain stimulation intervention on PSF. Our study will generate important information to guide the development of targeted intervention to mitigate PSF.